Deciphering the complexities of inflammasome activation following RSV infection

Abstract
Respiratory syncytial virus (RSV) is a leading cause of severe respiratory disease in children, the elderly and
immunocompromised individuals and there is currently no licensed RSV vaccine. The host inflammatory
response is believed to contribute to disease severity following RSV infection. Much less is currently known
regarding the role of RSV strains in modulating the host inflammatory response. The production of
proinflammatory cytokines IL-1β and IL-6 have been found to be significantly increased in the respiratory tract
of infants with severe disease. In addition, RSV infection has been reported to promote hypermetabolism in the
upper respiratory cells of RSV-infected children. IL-1β is a key proinflammatory cytokine and its secretion is
tightly regulated by multi-protein complexes named inflammasomes. Activation of the inflammasome is a two-
step process, including priming and activation steps, that requires metabolic reprogramming of the cell.
Previous studies have demonstrated that RSV A2 infection induces the activation of the NLRP3
inflammasome. Our preliminary data illustrate that infection with the RSV 2-20 strain results in significantly
increased IL-1β production as compared to infection with the A2 strain. We also observe an increase in
glycolysis in RSV 2-20 infected macrophages as compared to A2 infected macrophages. Unexpectedly, when
we infect cells with a recombinant RSV A2 strain engineered to express the 2-20 fusion (F) protein, termed
A2/2-20F, we observe a significant increase in both IL-1β production and glycolysis in macrophages. Thus, our
exciting new preliminary data indicate that RSV strains differentially activate the inflammasome and this strain-
dependent increased inflammasome activation is mediated by the F protein. Thus, important knowledge gaps
exist regarding how RSV-derived genes modulate the host inflammatory response. Our long-term goal is to
understand the virus-derived factors that modulate the host immune response and disease severity following
RSV infection. The objective of this application is to determine the changes that occur in inflammasome
signaling and metabolism following RSV infection. Moreover, we will explore how these changes impact innate
cell recruitment into the lung and shape the subsequent adaptive immune response. Our central hypothesis is
that the RSV 2-20 strain enhances both inflammasome priming and activation signals resulting in increases in
both neutrophil influx and the Th17 response. We will achieve the goals outlined above by pursuing the
following two specific aims: Aim 1. Determine the mechanism of RSV F protein-mediated inflammasome
activation. Aim 2. Examine the role of differential inflammasome activation on immune cell recruitment and
disease following RSV infection. The knowledge gained from these studies will provide a mechanistic
understanding of RSV-mediated inflammatory responses. In addition, these studies will greatly impact the
evaluation of therapeutic targets and design of future RSV vaccine candidates.

Public health relevance
Project Narrative Respiratory syncytial virus (RSV) is the leading cause of lower respiratory tract infection in children and is a cause of respiratory disease in the elderly and the immunocompromised. It therefore has a substantial impact on the healthcare of the US. The goal of these studies is to understand the factors that contribute to inflammation induced by the virus that contributes to the severity of disease.